Post-ischemic protection of white matter following an ischemic attack

Project Summary
Stroke is the leading cause of disability in the United States and around the world. The improved stroke care has
increased the number of stroke survivors. White matter injury (WMI) underlies the majority of clinical deficits
observed in stroke patients. Investigating the mechanisms of WMI is challenging in rodent brains due to the
smaller volume of WM compared to human brains. Because conventional animal stroke models mainly affect
gray matter, sparing the corpus callosum, WM protection has not been a primary target in many proposed
studies. A scientific gap therefore remains in the research into preserving WM function, which requires a
combination of an in vivo WMI rodent model with a clinically relevant approach to preserve WM integrity after
stroke. To address this scientific gap, we employed a consistent and reliable in vivo selective subcortical WMI
model that can be quantified histologically and with behavioral tests, and longitudinal imaging studies using MRI.
We previously showed that ischemia upregulates Casein Kinase 2 (CK2) causing WMI via Cdk5 and AKT/GSK3β
pathways. CX-4945, an FDA-approved selective and specific CK2 inhibitor that crosses the blood-brain barrier,
promotes axon function recovery by conserving mitochondria in WM when applied after ischemia. Since ischemia
activates NADPH oxidase (NOX) in neurons to increase oxidative stress causing mitochondrial dysfunction, we
propose a novel mechanism whereby CK2 activates NOX causing mitochondrial dysfunction during ischemia in
WM. WM mitochondrial dynamics and axon function show a sexually dimorphic age-dependent recovery after
an ischemic episode, because young female axons have better functional recovery with less interruption in
mitochondrial motility than young male axons, yet this difference is not observed within aging populations. These
findings warrant further investigation of post-ischemic benefits of CK2 inhibition in WM.
Our preliminary data show that the selective focal WM injury causes behavioral impairments indicated by loss of
bilateral paw use in the cylinder test and paw dexterity in the pasta-eating test. These deficits correspond with
persistent edema formation in scans obtained by using MRI modalities. Administration of CX-4945 at 6 hours
after stroke preserves WM integrity, alleviates behavioral deficits, and improves MRI modalities. Furthermore,
impaired mitochondrial motility following oxygen and glucose deprivation correlates with lower mitochondrial
respiratory function in live isolated mitochondria from WM. Because ischemia upregulates NOX enzyme activity
in in vitro WM injury and post-ischemic CX-4945 application attenuates NOX activity, we propose that CK2
inhibition after stroke confers WM protection and improves behavioral outcomes by regulating NOX activity to
conserve mitochondrial dynamics. We will test our hypothesis in both young and aging male and female WM in
an animal model of selective focal WMI.

Public health relevance
Project Narrative Improved stroke care has resulted in an increase in stroke survivors with long-term disabilities and with a higher risk of recurrent ischemic events. There is an urgent need to develop novel treatment options that protect both neuronal and axonal injury to improve the observed neurological disability in patients. We propose a novel approach, whereby using an FDA-approved CK2 inhibitor we can preserve the mitochondria function and protect the white matter after ischemia in both males and females.